Michigan Translational Imaging Program (M-TIP)

ABSTRACT
The Michigan T32 Translational Imaging Program (M-TIP) will comprise an innovative mixed MD and PhD
postdoctoral research training program led by the Department of Radiology, in conjunction with multiple
clinical, engineering and science departments (including Biomedical Engineering, Electrical Engineering,
Obstetrics and Gynecology, Orthopedic Surgery, Psychiatry, Radiation Oncology, and Urology), at the
University of Michigan (UM). The Program goal is to produce collaborative and broadly educated clinical and
basic science leaders in translational medical imaging, supported by an outstanding multidisciplinary
community of mentors, leveraging our extensive NIH-funded research in imaging and excellence in education.
It is widely acknowledged that diagnostic imaging and imaging-based treatments have transformed
medicine. However, medical imaging is complex, requiring knowledge from a variety of scientific and clinical
disciplines. The growing barriers to truly integrated collaboration among basic science and clinical imagers
include subspecialized knowledge bases, physical separation of researchers, differing scientific terminology,
clinical financial pressures, and complex regulatory pathways. The disconnect among basic and clinical
imaging scientists precludes clinical translation and eventual utilization of many technology developments.
The Department of Radiology and our partners at UM are uniquely positioned to address these challenges
by training a new generation of passionate translational imaging scientists, mentored by our team of basic and
clinical researchers whose laboratories touch upon every facet of translational medical imaging. The structure
and activities of M-TIP will be driven by the following Aims: 1. Foster the development and translation of
innovative imaging technologies by enabling seamless collaboration between basic and clinical imaging
scientists to enhance research training; 2. Create an enriched learning community of experienced imaging
mentors and passionate trainees, where organized didactic and discussion-based learning is used to impart all
facets of imaging technology translation; and 3. Guide mentees to become capable future mentors and leaders
in high impact imaging technology development and translation, both in industry and academia.
M-TIP’s Program Directors (Nicole Seiberlich, PhD; Vikas Gulani, MD, PhD; and Peter Scott, PhD) have
laboratories examining various aspects of MRI and nuclear medicine imaging. Our M-TIP faculty mentor roster
is comprised of PhD and MD imaging scientists with experience across the spectrum of medical imaging, from
technology development to clinical application. We will recruit basic science postdoctoral (PhD) fellows and
clinical residents and fellows (MD) as M-TIP trainees, with dual mentoring from paired teams of MD and PhD
faculty. By providing trainees with technical expertise, as well as communication, collaboration, research
ethics, and leadership skills, this multi-disciplinary program will prepare researchers for exceptional careers,
with the goal of developing and deploying useful imaging techniques to advance patient health and outcomes.

Public health relevance
PROJECT NARRATIVE The Michigan T32 Translational Imaging Program (M-TIP) will establish an innovative mixed MD and PhD postdoctoral training program led by the Department of Radiology, in conjunction with multiple clinical, engineering and science departments (including Biomedical Engineering, Electrical Engineering, Obstetrics and Gynecology, Orthopedic Surgery, Psychiatry, Radiation Oncology, and Urology), at the University of Michigan (UM). Leveraging UM’s outstanding resources in medical education, world renowned NIH-funded laboratories in basic, translational, and clinical research, and a diverse pool of highly experienced mentors, we will recruit basic science postdoctoral fellows and clinical residents and fellows who are passionate about imaging research to M-TIP. These mentees will work with both PhD and MD mentors on cutting edge and clinically relevant translational imaging projects and participate in interactive sessions focusing on technical aspects of imaging, communication, collaboration, and research ethics, with the ultimate goal of developing future leaders in translational imaging to advance health and outcomes for patients.